Confocal Microscopy for Engineering Stem Cell Microenvironment in Lymphatic Regeneration

PROJECT SUMMARY
The supplement fund is requested under PA-18-591 and NOT-GM-20-013 to purchase a confocal microscopy
system, which will support NIGMS MIRA award R35GM143055-01. The research program supported by this
award lies at the interface between engineering and medicine, with a motivation on making stem cells and
molecular therapies as an effective method to model and treat lymphatic diseases. Toward this goal, the research
program is working at the forefront of developing transdisciplinary approaches by combining stem cell and
bioengineering, biomaterials, and microfluidics, as well as lymphatic and systems biology techniques to develop
the necessary component in therapeutic lymphangiogenesis. Major amount of the work in the project now relies
on engineering stem cells and hydrogels for in vitro and in vivo models of lymphatic vasculatures in health and
diseases. The workflow relies on a rapid and reliable confocal microscope system, capable of imaging thick and
large samples. Technology currently available to the laboratory is aging, incompatible for imaging biomaterials,
requires advance scheduling, and necessitates paying costly user fees. The state-of-the-art, streamlined, and
single laboratory confocal microscopy system requested here will permit a more rapid advance toward the project
goals. The supplement fund is requested from NIGMS to cover 65% of the system cost. The remaining 35% will
be contributed by the University of Notre Dame as institutional support.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE STATEMENT) The supplement fund is requested under PA-18-591 and NOT-GM-20-013 to purchase a confocal microscopy system for the NIGMS funded research in which PI Donny Hanjaya-Putra serves as the principal investigator. This instrument will facilitate research program that focuses on strategies to utilize clinically relevant stem cells and synthetic materials to control lymphatic formation. The expected outcomes from this research program have the potential to advance our basic understanding of lymphatic vasculatures and create innovative therapeutics involving lymphangiogenesis for a wide range of diseases.